Biostatistics and Data Management Core

Project Summary/Abstract
Core C (Biostatistics and Data Management) provides expert guidance and collaboration in the
biostatistical and data management aspects of the design, conduct and analysis of translational
research projects generated by this program project application. Prior to the initiation of studies, Core
staff members consult with project investigators to help select designs that are efficient and adequately
powered. As studies proceed, staff members review data periodically to evaluate adherence to study
procedures, data quality, and adequacy of underlying statistical assumptions. When studies are
finished, staff members review the data again, produce informative summary tables and graphical
displays, conduct correct and efficient statistical analyses, and consult on the design of subsequent
studies. The work of Core C involves close integration with the efforts of all the research projects. Core
C staff members have extensive experience supporting cancer research, with strong backgrounds in
basic science, translational research, clinical trials, research computing, and data management. With
their many years of experience in biomedical research, they stand ready to identify and apply ideal
methods for the statistical design and analysis and data management of P01 research studies. Core C
offers its services to all P01 projects and cores.

Public health relevance
Project Narrative Core C (Biostatistics and Data Management) will provide expert guidance and collaboration in the biostatistical and data management aspects of the design, conduct and analysis of translational research projects generated by this program project application.